In vivo Assessment of Chemotherapy Remodeling of the Bladder Cancer Immune Microenvironment

ABSTRACT
In the United States urothelial carcinoma (UC) of the bladder is the 4th most frequent malignancy in men, and
there will be an estimated 80,500 new cases and 17,500 deaths in 2019. Despite being the most costly cancer
to treat over a patient’s lifetime, bladder cancer remains underfunded. High-grade (HG), muscle invasive
bladder tumors account for the majority of these deaths as patients with metastatic disease have a 5-year
survival rate of only 15%. In patients with clinically localized, muscle-invasive bladder cancer (MIBC), there is
a high level of evidence to support the use of cisplatin-based neoadjuvant chemotherapy. Two widely
accepted regimens with therapeutic equipoise are MVAC (methotrexate, vincristine, adriamycin, and cisplatin)
and GC (gemcitabine, cisplatin). While trials in advanced bladder cancer therapy are evaluating the
combination of chemo and immunotherapy, to rationally combine these two therapeutic modalities it is
imperative to precisely understand how MVAC and GC impact the immune microenvironment and how to best
sequence chemo and immunotherapy.
Preliminary studies from the Kim and Vincent laboratories show that MVAC and GC have differing
effects on the immune microenvironment in bladder cancers of the luminal molecular subtype. Tumors of the
luminal subtype, which have low baseline immune infiltration, have a significant increase in immune gene
signature expression and clonality of tumor-specific T cell receptor (TCR) clonotypes in the peripheral blood
after MVAC but not GC treatment. In contrast, GC significantly increases gene signatures known to promote
resistance to IC therapy in bladder cancer (Fibroblast TGFB Response Signature [FTBRS] and EMT-Stroma).
These results suggest that in luminal bladder cancers, MVAC promotes an inflamed tumor immune
microenvironment permissive to IC inhibition, while GC increases stromal activation, known to correlate with IC
resistance.
The diversity supplement candidate will leverage a novel, faithful, genetically engineered murine (GEM)
model of bladder cancer of the luminal molecular subtype as well as single cell RNA sequencing (scRNAseq)
to examine the effect of MVAC and GC at high resolution on the tumor microenvironment. Moreover, he will
determine the best sequence of administration of chemo and immunotherapy in these faithful models. The
comprehensive career development plan will teach presentation, writing, and networking skills to leverage for
the next steps in his career. Successful completion of this scientific work and training program will poise the
candidate for a selective, academic post-doctoral fellowship and an effective academic career.
1

Public health relevance
NARRATIVE This project will focus on understanding how chemotherapy used for bladder cancer alters the immune microenvironment of bladder tumors using faithful preclinical models of bladder cancer. 1